Cancer Research Informatics Shared Resource Facility

PROJECT SUMMARY/ABSTRACT
The Cancer Research Informatics Shared Resource Facility (CRI SRF) serves as a Markey Cancer Center
(MCC)-managed resource that develops and applies informatics methods and technologies to enable the
advancement of science through the curation and open investigator access to high quality data from a wide
variety of institutional sources. CRI has expanded MCC's data ecosystem to cover MCC's entire catchment
area of Kentucky through linkages and integration with high quality population-based data from the
Surveillance Epidemiology and End Results (SEER) Kentucky Cancer Registry. Enhanced and expanded
through CCSG support and implementing changes recommended from the last CCSG review, the CRI has
been highly innovative in the provision of comprehensive informatics services readily available to cancer center
investigators. Services are broadly categorized into: 1) provision of integrated data from the patient-centric
cancer research data warehouse; 2) research in clinical decision support for MCC's Molecular Tumor Board; 3)
high-performance computing (HPC) and big data storage support for bioinformatics analyses and machine
learning approaches to natural language processing (NLP); 4) data management to ensure complete and
accurate clinical trial and biospecimen data; 5) automated screening of eligible patients for clinical trial
recruitment; 6) identification and annotation of human biospecimens; 7) software and database development
for research and data dissemination; 8) informatics support for study planning and grant preparation; and 9)
mentorship, training and education. CRI services have been utilized by 103 MCC members, 55 of whom (53%)
are peer-reviewed funded members. CRI infrastructures and data management applications enable efficient
interactions among the Research Programs and other SRFs such as a portal for basic science researchers to
access bioinformatics analysis results. CRI develops and supports critical informatics technologies in
databases, data warehousing, NLP, deep phenotyping, HPC, mobile device apps, data sharing and data
dissemination. CRI closely coordinates the acquisition and provision of institutional informatics resources in
collaboration with the University of Kentucky (UK) Institute for Biomedical Informatics, the UK Center for
Clinical and Translational Science, UK HealthCare Information Technology and the UK Center for
Computational Sciences. CRI has established strategic alliances with informatics centers of excellence and
national agencies to enhance Kentucky data and to collaboratively develop informatics tools and data
standards serving the greater cancer research community. In addition, CRI faculty and staff serve as national
informatics leaders in cancer data exchange standards and innovative software applications adopted across
the United States. CRI is led by Dr. Eric B. Durbin (CP) and is tightly integrated with the Biostatistics and
Bioinformatics; Biospecimen Procurement and Translational Pathology; and Oncogenomics SRFs through the
provision of essential informatics services that enhance the other MCC SRF service offerings.